Nonlinear Analysis Research Core (NONAN)

Project Summary
The overall goal of the Nonlinear Analysis Research Core (NONAN) is to establish a unique
resource that will enhance the effectiveness of research in the Center for Research in Human
Movement Variability (MOVCENTR). The aims of the project are to 1) enable MOVCENTR
investigators to examine human movement variability data, 2) mentor all MOVCENTR
investigators in the examination of human movement data, and 3) build NONAN as the leading
resource for the University of Nebraska at Omaha, the state of Nebraska, the Great Plains
IDEA-CTR network, and beyond, specifically for use in human movement variability research to
treat and prevent motor related disorders. The NONAN Core is fundamental to the development
of the MOVCENTR as it is central to nearly all activities aimed at studying human movement
variability in order to treat and prevent motor related disorders. Institutional research capacity
will be enhanced by the fully established NONAN Core, substantially enhancing our
competitiveness for sustainable programmatic research grants and program projects.